Elucidating the mechanism behind oscillation between glycolysis and gluconeogenesis

Project Summary
Metabolism is a dynamic network of biochemical reactions capable of adapting to changing environments. In
changing glucose availability, glycolysis and gluconeogenesis support systemic glucose homeostasis. As
glycolysis and gluconeogenesis operate several common reaction steps but in opposite directions,
thermodynamics plays an important role in rapid oscillating between glycolysis and gluconeogenesis. In our
parent grant, we made a fascinating observation that even though cell lines with constitutively activated Ras and
Akt did not grow well under low-glucose high-lactate conditions, they proliferated rapidly under oscillatory
conditions between abundant glucose and no glucose. We hypothesize that the deficiency in gluconeogenic
enzyme expression caused by Ras and Akt renders these cells “inflexible” during the changing conditions and
this inflexibility ironically contributes to their rapid utilization of glucose as soon as it becomes available. A
corollary to this theory is that Ras- or Akt-activated cells may have more homogenous metabolism than healthy
cells during oscillatory environments and the metabolic heterogeneity may undermine adaptive competitiveness
in unstable fluctuating nutrient conditions. The goal of this administrative supplement application is to acquire
BioSpa-Cytation (Agilent Technologies) to investigate the role of metabolic heterogeneity within cell populations
in oscillatory nutrient environments. BioSpa-Cytation is an automated system that integrates incubator and multi-
mode microscopy for studying 2D and 3D cultures in programmable dynamic environments. The overarching
goal of the parent grant is to elucidate the regulatory mechanisms behind oscillation and coordination between
glycolysis and gluconeogenesis by integrating metabolomics, fluxomics, and thermodynamics (mainly using
mass spectrometry, isotope tracing, and quantitative modeling). The proposed equipment will provide the much-
needed dynamic cell culturing and high-throughput microscopy capabilities, allow us to gain coherent microscopy
and mass spectrometry insights, and ultimately lead to a greater success of the project in the parent grant.

Public health relevance
Project Narrative Glycolysis and gluconeogenesis are functionally opposite metabolic pathways that support systemic glucose homeostasis in humans. The project in the parent grant led to a hypothesis that the deficiency in gluconeogenic enzyme expression renders cell populations metabolically homogeneous and “inflexible” during the oscillating nutrient conditions and this inflexibility ironically contributes to their adaptive competitiveness. By integrating dynamic culturing and programmable multi-mode microscopy with mass spectrometry, we will test this hypothesis and gain coherent visual-molecular understanding of metabolism in homogeneous and heterogeneous cell populations.